Subcellular mechanisms of subtype-specific neuron vulnerability in ALS and FTD: dysregulation of synapse-localized RNA, protein, and translation in mouse models and human cortico-spinal assembloids

We propose to apply to amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) newly
developed subcellular approaches to investigate subtype-specific RNA, protein, and translational mechanisms
of selective vulnerability to closely molecularly and developmentally related cerebral cortex neurons. ALS and
FTD share genetics, and centrally involve degeneration of function-specific subtypes of subcerebral projection
neruons (SCPN): in ALS, corticospinal neurons (CSN) controlling voluntary movement; in FTD, closely related
von Economo neurons (VENs) and fork cells regulating emotion and cognition. Why these closely related
neuronal subtypes are especially vulnerable in ALS and FTD is unknown and likely key to therapy, since in both
patients and mice carrying variant genes of familial ALS or FTD (e.g. SOD1, TDP43, FUS, C9orf72), most
neurons in the brain and most body cells express the variant risk gene, including many known RNA processing
molecules, but only specific neuronal subtypes degenerate. Molecular differences between affected neuronal
subtypes and other types of even closely related neurons might render affected neurons more vulnerable to
dysfunction from mis-expression/mutation. By investigating vulnerable cortical populations and closely related
unaffected populations, we aim to identify novel subcellular molecular specificities, abnormalities, or distinctly
utilized pathways that render specific circuitry vulnerable to degeneration in ALS and FTD. This work will set a
foundation toward future therapeutics to prevent/limit degeneration of specific cortical circuitry in ALS/FTD.
We will quantitatively investigate subcellular RNA and protein localization (Aims 1, 3), and local
translational regulation (Aims 2, 3), in subtype-specific synapses and somata of vulnerable CSN/SCPN, both
in two complementary mouse models of ALS-FTD (hSOD1G93A Aims 1, 2; TDP-43Q331K Aim 3), and in refined
human iPS cell-derived “assembloid” fusions of a cortical-like (Co-l) and a ventral spinal cord-like (vSC-l)
organoid that exhibit remarkable neuron subset-specific projections and synapse formation from Co-l to vSC-l,
modeling SCPN circuitry in ALS-FTD (Aim 4). We apply subtype-specific soma and synaptosome purification
by FACS/novel small particle sorting with subtype-specific RNA-seq and new, ultra-low-input proteomics and
ribosome profiling to interrogate ALS/FTD at the intersection of genetic risk, RNA processing, and subcellular
specificity. We aim to identify subcellular molecular alterations in the affected circuitry, and to investigate
whether these molecular alterations are specific to the ALS/FTD-affected subtypes by comparison with
typically unaffected, but closely related cortical associative callosal projection neurons. This comprehensive
“subtype-aware” analysis has promise to uniquely identify potential distinctions in subcellular (synapse- and
soma-focused) RNA, protein, and/or translation as potential mechanisms of selective vulnerability. Together,
this venturesome work will provide foundational molecular and subcellular insight into selective
vulnerability of CSN/SCPN in ALS and FTD, merging new approaches across fields toward future therapy.

Public health relevance
Project Narrative ALS and frontotemporal dementia (FTD) are closely related degenerative disorders of closely related cerebral cortex neurons of very similar circuitry; corticospinal neurons (CSN) in brain and spinal motor neurons in spinal cord are selectively vulnerable in ALS, while molecularly and developmentally related “subcerebral projection neurons” (SCPN– von Economo neurons (VENS) and fork cells (FCs)– degenerate selectively in FTD, though mechanisms underlying subtype-specific vulnerability are unknown. This project employs recently developed subcellular approaches to RNA- transcriptomes, proteomes, and translational regulation to identify new candidate molecules and pathways contributing to selective vulnerability of CSN/SCPN in validated ALS mouse models, and in recent human induced pluripotent stem cell “assembloid” models that mimic elements of these cortical circuitries, by comparative investigations between wild-type, hSOD1, and hTDP-43 transgenic ALS mice and human cell-derived assembloids. To discover newly accessible molecular mechanisms that cause selective neuron vulnerability in ALS/FTD, we will compare RNA and protein localization and translation of RNA into protein across the vast spatial extent from cell body to axon tip synapse in ALS/FTD and wild- type mice and assembloids, employing new subcellular approaches: 1) RNA and protein localization to CSN/SCPN synapses and “parent” cell bodies– synapses are specialized subcellular structures that form precise connections and proper function; 2) local subcellular translational regulation in CSN/SCPN vs. uninvolved cortical neurons, in both synapses and cell bodies, in ALS vs. WT mice and assembloids; 3) integrative comparison of the two ALS/FTD mouse models and human-derived assembloids, cross-validating results at RNA, proteomic, and translational levels, as potential regulators of selective ALS/FTD degeneration.